INFRASTRUCTURE 1: CORE RESEARCH LABORATORIES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The services and methodologies provided to the Tuskegee University research faculty by the CORE I Research Laboratories significantly enhance their research capabilities. Current and prospective users, about 21 (the number varies as new faculty are recruited), represent 3 academic colleges and diverse scientific disciplines. 1. Imaging Facility: The facility provides EM, LM and gel imaging and analysis. Digital images are captured with a Kodak 290 used as Photoshop plug in or a Q Imaging CE camera operating through C Imaging Systems Simple PCI software (or as a Photoshop plug in) or MetaMorph software. Images are processed using Photoshop 7.0 or CS2 and analyzed with Fovea Pro 3 Image Analysis Tool Kit (Reindeer Graphics), C Imaging Systems Simple PCI 6, or MetaMorph software. Gels are analyzed with Kodak EDAS 290 software. Operations are run on Macintosh or Gateway E Series (Windows XP) computers. Fluorescence microscopy, has been greatly enhanced by the addition of a Leica DM 5000B (upright microscope) coupled to the existing Q Imaging CE digital camera (operating through C Imaging Systems Simple PCI software). This system allows the visualization and digital capturing of images of specimens tagged with multiple fluorescent probes and the fusion of the multiple images into a single photograph. Additionally, a Leica DM IRE2 (inverted fluorescent microscope) equipped with a cell incubation chamber has been acquired. This system is also equipped with a similar digital photography system and will allow the visualization of live cell experiments over extended time periods. These instruments were obtained with funds provided by CBR/RCMI and the NIH Export Grant (#3P20MD000195-05S1). This facility is used by the most investigators and has provided services to researchers from diverse disciplines including: Animal Science, Plant Science, Biology, Chemistry, Veterinary Biomedical Sciences and Pathobiology, and Material Sciences. 2 Cell Sorting / Flow Cytometry Facility: The Center acquired an Accuri C6 Flow Cytometer System. This system is administered by Dr. Clayton Yates and is primarily used by investigators from Biology and Veterinary Medicine. 3. Cell Culture and Molecular Biology Laboratories: These facilities provide laboratory space and molecular biology equipment to CBR/RCMI and other biomedical investigators. These laboratories easily receive the most "man-hours" of use of any of the CBR/RCMI CORE Facilities. Drs. T. Turner (CBR/RCMI funded project), R. Troy, M. Martinez, and C. Yates's (Non- CBR/RCMI funded projects) research teams use the facilities and equipment daily.